Mass Spectrometry and Surface Characterization Core

The Mass Spectrometry and Surface Characterization (MSSC) Core is a critical component of COBRE serving the diverse needs of researchers for mass spectrometric and surface characterization of biomaterials. In COBRE 111, the MSSC Core will (1) expand the scope of its instrumentation and scientific capabilities to include analysis of high-molecular weight samples; (2) upgrade and replace the current mass spectrometry instrumentation to maximize the impact of the core for COBRE research; (3) continue to provide support for structural analyses of small-molecule and polymer-based biomaterials.

Public health relevance
The ability to develop advanced biomaterials with customized control over morphological, mechanical and biological properties will lead to significant advancement in biomedical fields. The MSSC Core will provide mass spectrometry and surface characterization capabilities needed for the COBRE-based research. These capabilities will enable COBRE investigators to gain comprehensive understanding of the structure of the designed biomaterials and precursors, the knowledge critical to their ability to design biomaterials optimized for their intended biological applications.